Biomarkers and Altered Metabolic Pathways during Sleep Loss and Circadian Disruption

PROJECT SUMMARY/ABSTRACT
Approximately 50-70 million Americans suffer from sleep and wakefulness disorders and over 35% of Americans
sleep less than the recommended 7 hours per night. Additionally, ~20% of adults in the work force are shift-
workers and therefore have elevated risk of circadian misalignment (i.e. sleeping during the biological day and
wakefulness during the biological night). Health problems associated with insufficient sleep and circadian
misalignment include inflammation, depression and anxiety, drug abuse, reduced insulin sensitivity, diabetes,
and obesity. While the contribution of sleep to overall health is well recognized, many primary care providers fail
to diagnose or recognize sleep and circadian disorders and estimates show undiagnosed sleep disorders are more
prevalent than diagnosed sleep disorders. Currently, no clinical biomarkers of overall sleep and circadian health
exist. Developing such biomarkers has the potential to: 1) improve diagnosis of sleep and circadian disorders;
2) identify biochemical mechanisms underlying increased risk of cardiometabolic disease associated with
insufficient sleep and circadian misalignment; and 3) inform novel sleep and circadian based countermeasures.
Long-term, biomarkers of sleep and circadian health could also support the development of personalized
medicine, in part, by identifying individuals most likely to benefit from sleep and circadian based interventions.
The overall goal of this K01 is to identify biomarkers of sleep loss and circadian misalignment, and assess the
impact of increased sleep time on these biomarkers. I will use samples from two previously completed NIH-
funded laboratory based protocols to identify putative biomarkers of insufficient sleep and circadian
misalignment using plasma metabolomics and proteomics. I will also assess the plasma metabolome and insulin
sensitivity in a four-week trial that increases nightly sleep duration to the recommended ≥7 hours sleep/night in
habitual short-sleepers to determine if my identified biomarkers can discriminate these individuals between
baseline insufficient sleep and post-increased sleep time and if increasing sleep time improves insulin sensitivity.
This award will provide key training in four areas: 1) bioinformatics; 2) omics; 3) clinical translational sleep and
circadian studies and interventions; and 4) professional development, and will provide essential preliminary
data for an NIH R01 to help me launch an independent research program. The proposed outcomes support the
2011 NIH Sleep Disorders Research Plan to “enable sleep and circadian research training to inform science in
cross-cutting domains, accelerate the pace of discovery, and the translation of enhanced therapies from bench to
bedside to community”.

Public health relevance
PROJECT NARRATIVE Chronic sleep loss and circadian misalignment affect millions of people, representing an important public health issue. This project will identify blood biomarkers of insufficient sleep and circadian misalignment, and the impact of increasing sleep time on such biomarkers. I anticipate these findings will be a first step in establishing validated biomarkers of poor sleep and poor circadian health and will contribute to developing novel sleep and circadian interventions with the goal of improving cardiometabolic health.